High-throughput identification of common CD8+ T cell responses to SIV and M. tuberculosis in rhesus macaques

Project Summary/Abstract
Research towards a cure for human immunodeficiency virus (HIV) and mitigation of the impact of HIV/
tuberculosis co-infections are NIH priorities. Both research areas rely on studies of macaque monkeys
experimentally infected with simian immunodeficiency virus (SIV). Interventions to elicit effective CD8+
T cell responses to SIV and Mycobacterium tuberculosis (MTb) in macaques are under active develop-
ment. These studies are limited by the dearth of SIV- and MTb-specific CD8+ T cell responses restricted
by common macaque major histocompatibility complex (MHC) class I alleles.
We began addressing this problem in the previous grant period and identified dozens of novel CD8+
T cell responses in SIV and MTb, as well as in Zika virus, ebolavirus, and influenza. We also realized
that conventional T cell epitope discovery and characterization is unwieldy, slow, and cumbersome.
Consequently, we demonstrated that MHC class I binding to millions of peptides can be measured si-
multaneously, providing a transformative and extremely rapid way to define CD8+ T cell epitopes.
The purpose of this competitive revision is to use this new technology to define CD8+ T cell epitopes in
SIV and MTb restricted by 16 common macaque MHC class I alleles.
Specifically, we will:
Aim 1: Identify SIV and MTb CD8+ T cell responses restricted by 16 common macaque MHC
class I molecules. We will assess peptide binding of each 8-, 9-, 10, and 11-mer peptide in the pro-
teomes of every SIV and SHIV genome currently in Genbank and the MTb Erdman strain using an ul-
tradense peptide array. MHC:peptide tetramers will be produced for responses that are experimentally
validated.
Aim 2: Define peptide binding motifs for the 16 common MHC class I molecules by determining
the impact of every amino acid substitution at each residue in CD8+ T cell epitopes on peptide
binding. The peptide binding motifs can be used to improve algorithms for in silico prediction of
MHC:peptide binding.
Research resources from this study will be made available to the research community through real-time
sharing of peptide array data, deposition of experimentally validated CD8+ T cell epitopes in the Immune
Epitope Database, and distribution of MHC:peptide tetramers through the NIH Tetramer Core Facility.
Furthermore, the definition of CD8+ T cell epitopes using ultradense peptide arrays is generalizable and
could revolutionize the identification of pathogen-specific epitopes in all species, including humans.

Public health relevance
Project narrative We recently showed that millions of peptides can be assayed for binding major histocompatibility com- plex (MHC) class I molecules simultaneously. In this grant, we will use this technology to identify CD8+ T cell epitopes in simian immunodeficiency virus and Mycobacterium tuberculosis (MTb) that are re- stricted by common macaque MHC class I alleles with unprecedented throughput. These responses, as well as MHC:peptide tetramers that can specifically stain subpopulations of CD8+ T cells responding to these epitopes, are a vital research-resource for investigators studying HIV cures and HIV/MTb co-infec- tions -- high priority research areas in the trans-NIH plan for HIV-related research.